ROLE OF S-28 AND GLP-1 AS ENTEROINSULAR REGULATORS IN HEALTHY AND DIABETIC MEN

The effects of two gastrointestinal peptides, somatostatin-28 and glucagon-like peptide 1, on insulin secretion will be studied to examine the hormonal connections between nutrient absorption and glucose metabolism in healthy and diabetic subjects.